Endothelial and mural cell interaction in capillary malformation

Project Summary/Abstract: Capillary Malformation (CM) is one of the most common vascular malformations.
CM comprises enlarged vessels lined with sprouting endothelial cells (EC) and disorganized mural cells. In
Sturge Weber Syndrome (SWS), a neurocutaneous disorder, CM occurs in the skin, brain, and eyes. Patients
may suffer from seizures, strokes, glaucoma, and only symptomatic treatment is available. CM is caused by a
somatic mutation in GNAQ, the gene that encodes the a-subunit of the G-protein – Gaq. The GNAQ mutation
– the arginine (R) at the amino acid position of 183 replaced by the glutamine (Q) – is enriched in ECs isolated
from CM in the skin, brain, and choroidal vessels of the eye. To date, little is known about how the R183Q
point mutation in the Gaq activation domain leads to abnormal capillaries. Moreover, nothing is known about
the interactions between the mutant EC and neighboring mural cells surrounding CM vessels. Our preliminary
data suggest that lentiviral transduced human EC expressing the R183Q allele (EC-R183Q) have high levels of
pro-inflammatory markers, a weaker junctional barrier, and exhibit heightened response to laminar shear
stress. Immunostaining of CM tissue sections also reveal disorganization in mural cell environment labeled
with Desmin, Calponin, NG2 and alpha-SMA. Moreover, our histological analyses of CM tissue sections
revealed MRC1pos, LYVE1pos and CD68pos macrophage-like cells surrounding the CM vessels of the brain and
skin suggesting a pro-inflammatory environment. The goal of this fellowship proposal and training plan is to
examine how the EC-R183Q interact with both the mural cells and macrophages. I hypothesize that EC-
R183Q triggers the disorganized assembly of mural cells and subsequent macrophage attraction to the
abnormal vessels. The proposed study will test this hypothesis through the following aims: (1) to identify
paracrine interactions between EC-R183Q and mural cells (2) to identify and characterize mural cell and
macrophage interactions with EC-R183Q in vivo. Completing these aims will provide new insights into the
relationship between EC and the surrounding mural cells and macrophages in the CM. This fellowship training
will provide me with technical, communication, and mentoring skills to leverage my next step to independence.
Working with Drs. Joyce Bischoff and Arin Greene (co-sponsor) at Boston Children’s Hospital will provide me
with an excellent training environment from both the basic science and clinical aspect of the proposed work.

Public health relevance
Project Narrative: Capillary malformation, one of the common vascular malformations, is comprised of enlarged and destabilized capillaries. CM is caused by a somatic mutation in the gene GNAQ; the mutation changes the arginine (R) at amino acid position 183 to glutamine (Q), which is enriched in endothelial cells found in CM specimens. The proposed study seeks to understand the R183Q point mutation in the endothelial cells and how it affects interaction with surrounding mural cells in the CM using both in vitro and in vivo experiments.